The Michigan Department of Agriculture and Rural Development (MDARD) Animal Food Program (AFP) Animal Feed Regulatory ProgramStandards (AFRPS) Maintenance Track

The Michigan Department of Agriculture and Rural Development (MDARD) Animal Feed
Program (AFP) will enhance animal feed safety through the Animal Food Regulatory Program
Standards (AFRPS) Maintenance Track. The AFRPS cooperative agreement will maintain best
practices, enhance animal food safety and better direct regulatory activities aimed at reducing
foodborne illness attributed to animal feed safety hazards. Additionally, maintaining and
improving the eleven standards will provide greater efficiency, acceptance by FDA of MDARD
AFP field inspections and laboratory data, improve data quality and response time.
In this cooperative agreement proposal, MDARD AFP outlines goals and objectives on how it
will maintain a comprehensive strategic plan to continue significant conformance to AFRPS. In
this proposal, MDARD AFP also establishes its ability to continue working with the state
laboratory in order to guarantee valid and defensible laboratory testing data to protect human
and animal health.
The continuous improvement of MDARD's AFP through AFRPS will assist both Michigan and
the FDA to better direct regulatory activities toward increasing food safety in the United States
and move closer to the goal of creating a national, fully integrated food safety system.

Public health relevance
If chosen to participate in the Animal Food Regulatory Program Standards (AFRPS) Maintenance Track Cooperative Agreement, the Michigan Department of Agriculture and Rural Development (MDARD) Animal Feed Program (AFP) will continue to build, improve, and maintain the eleven standards, through completion of the following.